Pharmacology and Neurotherapeutics Program (PTNP)

The NIH Blueprint Neurotherapeutics Network (BPN) has initiated a series of collaborative drug discovery and development projects focused on nervous system disorders. These projects will be developing therapeutic leads through an iterative process of medicinal chemistry optimization and in vitro and in vivo testing. A component of this process will be the conduct of pharmacokinetic (PK) and toxicity assessment of compounds developed through the BPN. This task will cover all tasks related to general contract administration for the period of 9/13/2012-9/12/2013.